Regulation and evolution of extreme metabolic plasticity in eusocial animals

Project Summary
Essentially all multicellular animals exhibit some form of metabolic plasticity in response to environmental or
internal cues. This project seeks to increase our understanding of how metabolic and stress response pathways
interact and are regulated and at both the cellular and organismal levels, as well as the mechanistic basis for the
limits to this plasticity. The focus of this work is on an innovative system, ants, which feature extreme disparity in
metabolism between phenotypic classes of individuals (“castes”) within the same nest. Importantly, these
differences are not genetic, but instead the product of environmentally-determined plasticity.
The species focused on in this work (Harpegnathos saltator) is particularly well-suited for understanding plasticity
of stress resistance and metabolism: any individual can be induced to change caste – from non-reproductive to
reproductive – in the lab on the order of days, a change that is fully reversible on the same time scale. I show
evidence that changing caste results in a rapid, striking shift in global metabolism, consistent across multiple
tissues, under the control of behavioral/social stimuli. Importantly, these shifts, which can be recapitulated in
vitro, show strong evidence of engaging both metabolic and stress-response pathways typically seen as mutually
exclusive, likely due to eusocial evolution uniquely prioritizing very high anabolism as well as long-lifespan in
reproductive individuals. Further, comparative analyses reveal strikingly-similar signatures of gene expression
between castes of one of the only eusocial mammals, suggesting evolution of eusociality may converge on
regulation of these hugely-important pathways in multiple independent taxa.
The proposed work will utilize in vivo and in vitro experiments in ants, D. melanogaster, and the Naked Mole-rat
to understand how the Unfolded Protein Response (UPR) and MYC-hyperactivity paradoxically appear to both be
acting in a novel way to accomplish the metabolic differences between castes, how these differences are
regulated organism-wide, and if the same regulation has evolved in a eusocial mammal. We will utilize custom
antibodies and perturbations in vitro and in vivo to identify core components and unique upstream effectors,
neuronal cultures that transcriptionally recapitulate castes to understand the hormonal regulation of this plasticity,
and work with the Naked Mole Rat to understand how these signatures appear to have also evolved in a eusocial
mammal. This work will not only shed light on the regulation and evolution of metabolic plasticity at both the
cellular and organismal levels, but also how ants uniquely engage multiple conserved, medically-relevant
metabolic regulators to uniquely accomplish a high-metabolism stress-protected state not seen in other systems.

Public health relevance
Project Narrative Essentially all multicellular animals exhibit metabolic plasticity in response to changes in environmental or internal stimuli, and defects in metabolic plasticity are associated with a vast number of disease states. This work will utilize a novel system to study the regulation of metabolism, ants, which not only exhibit drastic, inducible metabolic plasticity, but also strong evidence of unique engagement of highly-conserved metabolic and stress- response pathways classically seen as mutually exclusive. Results from this project will provide important insight on the regulation of and limits to metabolic plasticity, as well as establish a unique system extremely well-suited for such studies.